CTSA Predoctoral T32 at the University of Texas Health Science Center at Houston

Training future generations of researchers to think critically and collaborate effectively in
cross-disciplinary team environments is essential to the advancement of translational science in
the United States. With the accelerating pace of discovery in biomedical science, the need for
translational scientists is greater than ever. The goal of this predoctoral T32 application is to train
six translational science researchers at the predoctoral level who will build a community of clinical
and translational scientists by leveraging the multi-institutional, multidisciplinary strengths of the
Center for Clinical and Translational Sciences (CCTS) at The University of Texas Health Science
Center at Houston (UT-H). Thanks to a TL1 grant that preceded this application and was awarded
as the training core of the Clinical and Translational Science Award, we have a successful track
record of training a productive group of translational researchers. Former predoctoral trainees
supported by the TL1 grant have been enrolled in The University of Texas MD Anderson Cancer
Center UTHealth Houston Graduate School of Biomedical Sciences (UT-GSBS), which offers
rigorous discipline-specific training in a number of research concentrations, such as cancer
biology, molecular and translational biology, pediatric oncology, advanced rheumatology, and
neuroscience. Moreover, what sets our CCTS apart is the number of partner institutions spanning
the state of Texas. In this predoctoral T32 proposal, we will continue to train leaders in
translational science while integrating trainees from CCTS partner institutions. This will bring
additional strength to the T32 as these trainees will draw upon various health-related trends
throughout Texas. Furthermore, the training faculty and their mentees at the CCTS partner sites
will bring awareness of unique research topics and collaborative opportunities to the forefront of
the T32 trainee experience for those based in the Texas Medical Center (TMC). The following
aims will enable us to achieve this goal: 1) Attract and retain predoctoral trainees with the
potential to develop into leaders in translational science, and 2) Leverage the strengths of the
unique CCTS ecosystem to train predoctoral fellows in principles of translational science.
We will utilize the world-class educational and research opportunities of the TMC to carry out
these aims and train translational scientists across the state. By drawing upon the trainees
available at our partner institutions that grant doctoral degrees, the training program is uniquely
positioned to create the translational science leaders of the future. We anticipate the predoctoral
T32 program will create a valuable pool of translational scientists who are innovative, productive,
and capable of addressing the health needs of a wide-ranging populace.

Public health relevance
Thanks to a TL1 grant that preceded this application and was awarded as the training core of the CCTS, we have trained 94 productive translational researchers, 31% of whom are faculty at domestic academic institutions and are actively working to improve public health through their work. In the proposed program, we will continue to train emerging leaders in translational science while integrating trainees from CCTS partner institutions in South and East Texas. Collectively, our partner institutions represent a vast pool of talent from which we can draw upon for additional T32 trainees to become leaders and innovators in bringing the benefits of translational science to all Texans.